Burden and Risk of Neurological and Cognitive Impairment in Pediatric Sickle Cell Anemia in Uganda (BRAIN SAFE II)

Abstract
Stroke commonly occurs in children with sickle cell anemia (SCA) due to development of sickle
cerebral vasculopathy (SCV) injury. SCV also can cause neurocognitive impairment. Identifiable
stroke risk is associated with abnormal cerebral abnormal arterial blood flow detected by
transcranial Doppler ultrasound (TCD). Most children with SCA live in Africa. Our hypotheses are
that: 1) Higher burden of anemia, inflammation and malnutrition predispose African children with
SCA to greater burden of SCV than in the West; 2) in Uganda, HU therapy will prevent, stabilize
or improve SCV and its effects. We propose to: in Aim 1 to perform an open label, single arm
clinical trial to test the three-year impact of hydroxyurea treatment for a cohort of children with
SCA ages 2-9 years in Uganda on each of three clinically important outcomes: abnormal TCD,
neurocognitive impairment, and first stroke. Following baseline assessments, all subjects will
begin hydroxyurea therapy at about 20mg/kg daily. Changes in the frequency and severity of each
outcome will be compared with age-adjusted baseline test results by repeating these three tests
at 18 and 36 months; in Aim 2 to evaluate the impact of HU on structural vascular injury using
MRI and MRA in a randomly selected 33% subset of this cohort at baseline and at 36 months; in
Aim 3 we will assess changes to biomarkers of anemia, C-reactive protein and malnutrition status
during hydroxyurea therapy, over time, compared with baseline levels, and determine their
relationship to the development of brain injury and the other findings. Our proposed intervention
with hydroxyurea is the only Africa-based trial to broadly prevent or ameliorate manifestations of
SCV.

Public health relevance
Narrative We are proposing an open label, single arm trial to test the three-year impact of hydroxyurea treatment for children with sickle cell anemia on each of three clinically important outcomes: abnormal arterial brain blood flow, neurocognitive impairment and first stroke. Brain imaging and biomarkers will be correlated with these outcomes over time.